Targeting CD83 to reduce leukemia relapse and GVHD after allogeneichematopoietic cell transplantation

PROJECT SUMMARY
Post-transplant cyclophosphamide (PTCy) has substantially reduced the risk of lethal graft-versus-host disease
(GVHD) after allogeneic hematopoietic cell transplantation (alloHCT). However, like other forms of GVHD
prophylaxis, PTCy still relies upon passive graft-versus-leukemia (GVL) to prevent disease relapse.
Progression-free survival after alloHCT is largely limited to 41-50%. Thus, concurrent GVHD and leukemia
relapse prevention remains a critical unmet need in transplantation. Innovation in alloHCT must now
maintain GVHD prevention at the level of PTCy and add tools to directly reduce relapse and not simply
maintain or preserve GVL. Distinct from pharmacologic immune suppression, we have developed novel,
human, CD83-targeted chimeric antigen receptor (CAR) T cells for concurrent protection against relapse of
CD83+ leukemia as well as GVHD. CD83 is a member of the immunoglobulin superfamily. We show CD83 is
expressed on human myeloid leukemia (AML), acute lymphoblastic leukemia (ALL), and alloreactive T cells
implicated in GVHD. Importantly, we have demonstrated that CD83 CAR T cells kill leukemia in vivo and
eradicate GVHD without impairing antiviral immunity. Further, CD83 is largely absent from hematopoietic stem
cells, myeloid progenitors, and neutrophils, limiting the risk for on-target/off-tumor toxicity or myeloid aplasia.
We also developed an ‘OR’ logic gated CD19/CD83 CAR T that can kill B cell ALL that expresses either CD19
OR CD83 via a shared activating endodomain. We show that our ‘OR’ gated CD19/CD83 CAR T can
overcome CD19 antigen loss, which is clinically seen in 25% of ALL patients after treatment with CD19 mono-
CAR T. In this application, we will (Aim 1, mouse experiments) test whether human CD83-targeted CAR T cells
can concurrently prevent leukemia relapse and GVHD, as compared to standard PTCy. To parallel expected
initial clinical trials, we will also investigate the sequential use of CD83 CAR T consolidation after PTCy to
eliminate leukemia relapse and GVHD. Our preliminary data demonstrates that CD83 is expressed on CD4+
conventional T cells during acute GVHD, as well as B cells and T helper follicular cells during chronic GVHD.
Thus, (Aim 2, biomarker validation study) we will investigate whether CD83 is a biomarker and therapeutic
target among effectors of acute and chronic GVHD onset and therapeutic response. Successful completion of
this work will guide the seamless transition from discovery to clinical translation of human CD83 CAR T cells to
concurrently eliminate life-threatening relapse and GVHD after alloHCT.

Public health relevance
PROJECT NARRATIVE While allogeneic hematopoietic cell transplantation can cure high risk leukemia, relapse and graft-versus-host disease (GVHD) account for over 60% of deaths post-transplant. Taking advantage of the differential expression of CD83 on acute myeloid and lymphoblastic leukemia, as well as effector cells of acute and chronic GVHD, we have developed human CD83-targeted chimeric antigen receptor (CAR) T cells that can simultaneously protect transplant recipients from relapse and GVHD. In this application, we will test human CD83-targeted CAR T in eliminating the two major causes of post-transplant mortality using established xenogeneic models and determine whether CD83 is a therapeutic target and biomarker of acute or chronic GVHD.